Human natural killer cells: Advancing biology and clinical applications

ABSTRACT
The traditional “standard of care” for cancer over the past several decades has consisted of surgery, radiation
therapy, chemotherapy, and stem cell transplantation in some cancers such as acute myeloid leukemia. In the
last decade, immune therapy using monoclonal antibodies such as rituximab and traztuzumab have now been
incorporated into the standard of care for lymphoma and breast cancer, respectively. Compelling data now
shows that that innate immune cells, such as natural killer (NK) cells are an important component mediating
the clinical effectiveness of antibody therapy. Our proposal aims to strengthen cellular innate immunity to
enhance cancer therapy. Part of the challenge relates to 1) limited recognition of tumor cells by innate immune
effector cells; 2) dampening of innate immune effector cell function in the tumor microenvironment; and 3)
penetration of the tumor mass by innate immune effector cells.
Our vision is to add activated, tumor antigen specific innate immune effector cell therapy to the existing
armamentarium against both liquid and solid tumors. Strategically, this will be accomplished over the next 7
years through: 1) a more complete understanding human NK cell development, including the expression of
activating and inhibitory receptors; 2) optimizing the development of human NK cells expressing chimeric
antigen receptors, and 3) full development of our bi-specific NKG2D antibody that will bring human NK cells
and other innate immune effector cells into the tumor bed. Our documented consistent success with basic
research on NK cell development and effector function over decades, along with our successful translation of a
multitude of our discoveries to the clinic in over 1,000 cancer patients both serve as a foundation for us to
successfully proceed along this pathway. In the next seven years, we believe we will lead the field in: 1)
enhancing NK cell tumor specificity; 2) enhancing NK cell cytolytic effector function; and 3) enhancing
migration of NK and other innate immune cells into the tumor bed. The potential outcome over the next 7 years
will be the completion of a series of clinical trials that first demonstrate significant anti-tumor activity in man and
ultimately demonstrate significantly prolonged survival of cancer patients bearing liquid or solid tumors that
express antigens to be recognized by our modified innate immune products.

Public health relevance
PROJECT NARRATIVE Natural killer (NK) cells serve as a crucial first line of defense against cancer. Funding of this proposal will advance our understanding of basic immunology on human NK cells as well as advance the development of NK cell-based immunotherapy to treat cancer. The knowledge and therapeutic advances obtained from this study will add a new dimension to the armamentarium against cancer.